Neurophysiologic correlates of training-induced locomotor learning post-stroke

ABSTRACT / PROJECT SUMMARY
Most stroke survivors present with gait dysfunction resulting in reduced community participation and quality of
life. A promising rehabilitation intervention for mitigating post-­stroke gait deficits is the combination of fast
walking and functional electrical stimulation (FastFES). Dr. Trisha Kesar (primary mentor) is currently leading
an NIH funded R01 comparing the long-­term effects (18 sessions and up to 12-­week follow-­up) of FastFES
versus conventional Fast on walking function and corticospinal excitability. Despite its promise, FastFES, like
virtually all gait interventions, faces the problem of variation in individual response to treatment.
Neurophysiological testing takes aim at the root of this problem by exploring the neural mechanisms underlying
each individual’s unique response. Because neuromotor circuit plasticity is a core component of treatment
response, quantifying this adaptation potentially provides a means for identifying likely responders and non-­
responders early in the treatment process. A promising tool for non-­invasively assessing changes in
corticomotor excitability is transcranial magnetic stimulation (TMS). In fact, TMS response has already been
correlated with retention of functional improvement in other post-­stroke motor interventions. However, whether
TMS-­derived measures correlate with response to Fast or FastFES training is unknown. Additionally, TMS-­
induced measures do not differentially account for changes at the spinal reflex circuit or the motoneuron level,
which can be evaluated by measuring H-­reflexes in response to peripheral nerve stimulation, another non-­
invasive technique that can probe spinal circuit neuroplasticity. Thus, I propose to gather additional TMS and
H-­reflex data prior to and following the first training session in Dr. Kesar’s parent R01 study, which will be
compared to biomechanical changes during and at 48-­hours following (retention) the training, to test the
hypothesis that baseline corticomotor and spinal excitability, as well as training-­induced acute neurophysiologic
responses to Fast and FastFES are associated with locomotor learning of biomechanical improvements.
Finally, corticomotor or spinal circuit changes in response to a single intervention do not indicate whether an
individual who exhibits a ‘response’ or non-­response to the treatment does so due to poor intervention
matching or a generalized decrease in neuroplasticity capacity. Thus, I propose a baseline measurement of
individual responses to paired associative stimulation (PAS), a non-­invasive method to quantify an individual’s
capacity for neuroplastic change. We hypothesize that baseline PAS response will be associated with
biomechanical and neurophysiological response to the gait treatment. In addition to providing novel insights
into neural correlates of acute responses to stroke gait training, this F31 project will provide the PI valuable
training in collection, processing, and interpretation of neurophysiologic data under the supervision of an elite
mentoring team comprising experts in neuromechanics processes of clinical gait rehabilitation (Kesar),
neuroplasticity and PAS (Borich), and corticospinal physiology (Nichols).

Public health relevance
PROJECT NARRATIVE This project involves the collection of data related to connections between the brain, spinal cord and muscles in stroke survivors before and after they receive a clinically- relevant walking treatment. The goal of this work is to determine if baseline status of or changes in the strength of these nervous system connections can help rehabilitation clinicians and researchers identify who is most likely to show a positive response to gait training treatments comprising treadmill walking with or without electrical stimulation. Our long- term goal is to utilize non- invasive measures of nervous system excitability to identify likely responders and non- responders to clinical gait treatments, therefore helping to personalize rehabilitation and maximize its positive impact on walking function and quality of life in people with neurological disabilities.